Omic Approaches to Factor VIII Inhibitor Development in Hemophilia Patients of Mexican Descent

PROJECT SUMMARY/ABSTRACT
Bleeding in Hemophilia A (HA) is currently prevented by regular infusions of therapeutic factor VIII (FVIII) proteins
(tFVIIIs). Unfortunately, ~30% of all severe HA patients (HAPs) develop antibodies called FVIII inhibitors (FEIs)
that neutralize tFVIIIs and greatly increase morbidity & mortality. FEIs develop significantly more often in HAPs
with Mexican ancestry (MA) vs. non-Hispanic white (NHW) ancestry. This research seeks to identify genetic and
environmental variables underlying the high incidence of FEIs in HAPs of MA by applying novel omic approaches
in a powerful systematic immunoepidemiologic study of the immunogenicity of tFVIIIs. We will leverage a unique
resource, the My Life, Our Future (MLOF) repository, which has ~400 such subjects already enrolled in our study.
We have four main aims. Aim 1: To enroll and extensively characterize a cohort of 200 severe HAPs with
MA. We will recruit 200 severe HAPs (including 30 sib pairs) in the US and Mexico. Relevant clinical data and
blood samples will be collected to assess FEI risk. We will use the (i) WGS and mRNA-Seq data from these 200
new individuals plus the ~400 subjects of MA in the MLOF project (N=600) and (ii) functional CD4 T-cell data
from all 200 new subjects. We will assess intracellular (i) CRM status (i.e., presence or absence of FVIII antigen)
in all 200 new subjects, as this variable underlies the contribution of F8 mutation type to FEI risk. Aim 2: To
elucidate the genetic basis of FEI risk in MA severe HAPs using trans-omic endophenotypes. Using a
novel statistical genetics approach employing both close and distant relatedness in the overall sample of ~600
MA severe HAPs, we will identify endophenotypes genetically correlated with FEI risk from novel phenotypic
measures immunologically related to FEI development. The best endophenotypes for FEI risk will be genetically
characterized using both quantitative genetic methods and variant-specific association analyses. Aim 3: To
detect and characterize environmental effects on FEI risk. Using a novel statistical genetic approach to
maximize systematic environmental signals influencing FEI risk, we will search for environmental traits reflected
in high-dimensional transcriptomic biomarkers that are correlated with FEI development. Aim 4: To perform a
case/control peptidomic analysis of FEI risk. We will select a subset of 40 HAPs as 20 FEI discordant sib
pairs (one brother has a FEI and the other does not) and recruit their carrier mothers. We will characterize each
subject’s tFVIII peptidome, i.e., the HLA-class-II (HLAII)-bound collection of tFVIII-derived-peptides (tFVIII:dPs)
that are presented to their CD4 T-cells. We will then identify the “culprit tFVIII:dP” and “offending HLAII allele”
(OHA), which are most correlated with FEI development in the proband of each sib pair. Finally, we will evaluate
the relevance of our findings using: 1) CRISPR/Cas9 to knockout (ko) specific OHAs in their B-lymphoblastoid
cells (BLCs) in vitro; and 2) their ko BLCs for functional T-cell studies. As tFVIIIs are more immunogenic in HAPs
with MA, this study is likely to identify new determinants of FEI risk (both genetic & non-genetic) which will assist
the development of new (i) diagnostics that are more accurate, (ii) therapeutics with improved safety and efficacy,
and (iii) management strategies that reduce race- and ethnicity-based disparities in health outcomes.

Public health relevance
PROJECT NARRATIVE Patients with severe Hemophilia A (HA) experience frequent bleeding—often spontaneously—because they inherit an X-chromosome from their mother that has a mutation in the gene which makes a critical blood clotting protein called factor VIII (FVIII). As a result, they don’t make any (or only very little) of this essential blood clotting protein. Thus, bleeding in severe HA-patients (HAPs) is currently prevented by regular infusions of a therapeutic (t) FVIII protein (tFVIII) product. Unfortunately, ~30% of all severe HAPs develop antibodies called “FVIII inhibitors (FEIs)”, which neutralize tFVIIIs and greatly increase morbidity and mortality. FEIs develop in ~40-45% of severe HAPs with Mexican ancestry (MA) but in only ~20-25% of those with European ancestry. This research, which we refer to as the “Trans-omics for FVIII Inhibitor Causation (TRAFFIC)” study, seeks to identify genetic and environmental variables that underlie the high incidence of FEIs in HAPs with MA.